RHUBARB AND ANGIOTENSIN CONVERTING ENZYME INHIBITOR STUDY RACE II

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Patients in China has suggested that rhubarb extract when used alone is equivalent to the protection afforded by ACEI. Furthermore when used in combination with ACEI, the renoprotective effect of rhubarb appears to be additive. Rhubarb extract is a chinese herbal preparation that is used extensively in china and other asian countries to treat constipation and CKD. Its mechanism of action in preventing progression of CKD is uncertain but perhaps related to TGF beta and TNF alph inhibition. The proposed study will be a prospective randomized double blinded placebo controlled study design to evaluate the efficacy of Rhubarb in addition to ACEI in proventing progression of CKD in adult patients with diabetes.